OSMOTIC STIMULATION OF VASOPRESSIN SECRETION IN HEALTHY HUMANS

The goal of this study is to compare changes of plasma vasopressin levels and thirst sensation induced by two different diagnostic tests (hypertonic saline infusion test vs. water load/hypertonic saline test) routinely used for evaluating osmoregulatory function.